Integration of Raman Spectroscopy and Optical Coherence Tomography (RS-OCT) for In-Vivo Identification of Bacterial Otitis Media

PROJECT SUMMARY
Otitis media (middle ear infection) is a highly prevalent disease, especially in young children. It has been
documented that more than 75% of children will have at least one episode of otitis media (OM) by age 3, and
many children will have recurrent or chronic OM. In most cases, diagnosis of an ear infection is performed based
on the appearance of the tympanic membrane and presence of fluid via an otoscope. In the absence of a method
to identify bacterial infections, broad-spectrum antibiotics are prescribed without definitive knowledge of whether
i) an active infection present, and ii) whether it is a bacterial infection (versus a viral infection). Previous clinical
data also suggests that antibiotic therapy is only effective for one-third of OM patients, with two thirds of cases
likely caused by antibiotic resistant bacteria, or more likely, viral pathogens, resulting in a misdirected expense
of more than $700 million, annually. Therefore, there is a clear and urgent need for a point-of-care diagnostic
tool to determine the presence of an active infection and whether an infection is bacterial in origin. Further, if we
can distinguish the bacterial species present, unnecessary administration of broad-spectrum antibiotics can be
eliminated, thus improving the efficacy of treatment and management of this highly prevalent disease. This
proposal seeks to fulfill this unmet need by developing integrated Raman Spectroscopy-Optical Coherence
Tomography (RSOCT) for the real-time detection and bacterial differentiation of pathological microorganisms in
the middle ear. The scientific premise of the proposed research is that OCT can be used for image-guided
placement of the RS probing beam, as well as visualization of any biofilm affixed to the tympanic membrane
which would be indicative of a bacterial infection. This imaging system will be coupled with Raman spectroscopy
for a more direct assessment of any biofilm and/or effusion by determining the presence of OM-causing bacteria
and speciation via its biochemical fingerprint. The overall objective of the project will be accomplished by
technological innovation and integration, followed by a series of systematic in vitro, ex vivo, and in vivo human
studies with rigorous data analysis methods outlined in the specific aims. This research will have a profound
impact on how we diagnose and care for these common ear infections. Most importantly, this project will provide
critical data (identifying specific bacterial species) to monitor the development of antibiotic resistance, to reduce
the overuse of antibiotics, and ultimately, to efficiently improve the health of patients.

Public health relevance
PROJECT NARRATIVE In the absence of a point-of-care diagnostic approach that can identify bacterial infections, pediatric patients with middle ear infection or otitis media (OM) are frequently prescribed broad-spectrum antibiotics, resulting in more than $700 million annually that is lost due to over-prescription of antibiotics, and only effective for one third of OM patients. An integrated Raman Spectroscopy-Optical Coherence Tomography based diagnostic tool has the potential to provide real-time imaging and rapid detection and speciation of bacterial microorganisms in the middle ear, eliminating unnecessary administration of antibiotics (in non-bacterial cases) and monitoring possible development of antibiotic resistance. Ultimately, this project will improve the diagnosis and efficacy for the treatment and management of this prevalent disease that occurs in more than 75% of children by the age of 3.